Developmental Core

PROJECT SUMMARY – Developmental Core
HIV/AIDS remains an important public health issue, especially in the Southern United States, where the rise in
opioid use disorder is associated with an increased number of HIV-1 infections. To accomplish the CFAR
research missions that include preventing new infections, increase access to care, reduce health disparities
and inequities, and improve health outcomes for people with HIV, skilled researchers are needed. The goals
of the Duke Center for AIDS Research (CFAR) Developmental Core are to stimulate new HIV/AIDS research
programs targeting the most relevant issues facing people with HIV, and to train and support the next
generation of HIV/AIDS researchers to ensure local, regional, and national HIV/AIDS research priorities are
addressed. To accomplish these goals, the Core proposes three areas of activities including financial support
for pilot research projects, development of professional networks through recruitment of HIV/AIDS researchers,
and a structured mentoring program. In the next funding cycle, the Developmental Core will provide financial
support to develop new research programs that address NIH priority HIV/AIDS research, particularly the
Southern HIV Epidemic and the impact of opioid use disorder on HIV/AIDS and co-morbidity. The
Developmental Core also works with other Departments, Centers, and Institutes to recruit promising new
HIV/AIDS researchers to the Duke faculty. The Developmental Core provides mentoring and career
development support to assist the growth of the next generation HIV/AIDS researchers, such as support for
junior investigators to enhance their ability to receive independent funding and engagement of established
investigators from outside the field. The activities of the Developmental Core also support Duke CFAR overall
aims of support the overall aims of the Duke CFAR including, “Continue development of a pipeline of next
generation HIV/AIDS investigators through strong support of Early Stage Investigators and engagement of
established investigators from outside the field”, “Foster critical synergies through Core-Core interactions and
engagement of new and existing strategic partnerships” and “Further enhance and support inter-CFAR
collaborative activities”.